An extracellular vesicle component as a candidate to control cryptococcosis.

An extracellular vesicle component as a candidate to control cryptococcosis.
SUMMARY
Fungal diseases are a major threat to immunocompromised patients. Cryptococcosis, caused by members of
the Cryptococcus genus, is responsible for nearly 200,000 deaths worldwide annually. Immunocompromised
individuals are the primary population that develop cryptococcal meningoencephalitis, a 100% fatal condition if
left untreated. C. neoformans, the most common causative agent of cryptococcosis, has recently been
classified as a critical threat by the World Health Organization. Despite their devastating impact on human
health, fungal diseases have been consistently neglected, as demonstrated by the lack of available antifungal
vaccines and our limited antifungal armamentarium. The Rodrigues and Nosanchuk laboratories have
collaborated actively for over 15 years in the field of fungal infections and have extensively characterized
fungal extracellular vesicles (EVs) in various models. EVs play crucial roles in fungal physiology and
pathogenesis. Recently, we discovered that the tripeptide isoleucine-proline-isoleucine (IPI), a small molecule
component of EVs, effectively controls cryptococcal infection in an invertebrate host. IPI acts as an inhibitor of
dipeptidyl peptidase 4 (DPP4), which plays a role in fungal pathogenesis, as well as in host physiology, by
regulating insulin and glucose. In this proposal, we aim to investigate the participation of IPI and DPP4 in
fungal immunopathogenesis through three specific aims. Aim 1 will explore the protective mechanisms of IPI in
animal models of cryptococcosis. Aim 2 focuses on understanding the roles of fungal and host DPP4 in
disease progression, including their impact on glucose metabolism and the immune response. Aim 3 seeks to
determine the relevance of IPI and DPP4 in other fungal models. Successful completion of this project will
provide a comprehensive characterization of a novel candidate for combating cryptococcosis and perhaps
other diseases. Furthermore, we anticipate gaining insights into the connection between DPP4 and fungal
pathogenesis. This proposal aims to foster intercontinental collaboration and enhance the capabilities of
Fiocruz, the Brazilian institution leading this collaborative effort.

Public health relevance
PROJECT NARRATIVE Fungal diseases are a major threat to human health, and cryptococcosis, caused by Cryptococcus, kills nearly 200,000 people each year. This program will take a multidisciplinary approach to define the effects of a small peptide molecule produced by Cryptococcus and its target enzyme on the outcomes of this lethal fungal infection with the intent of developing insights on the infection process and to develop novel treatments to fight the disease.